Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE:
The Stanford Aging & Ethnogeriatrics Transdisciplinary Collaborative Center's (SAGE) brings together a variety of
scientific and medical disciplines to advance knowledge of aging through research integrating biological, social and
behavioral sciences on emerging research methodologies (including precision medicine, big data science, digital health,
virtual reality and others). The primary focus of the Administration Core is to provide leadership, training, recruitment,
and financial oversight. This core will guide, coordinate, and facilitate best practices of the other cores' activities,
ensuring timely and ongoing cross-core communications to achieve the collective aims. An Executive Committee will be
responsible for the overall scientific and administrative goals and objectives of the SAGE program. The Administration
Core will receive oversight, input and support from the SAGE External Advisory Board. By providing an integrated
infrastructure for the logistical and management requirements of the center components, the Core will increase
productivity, enhance efficiency, and promote unified efforts toward achieving the center's goals.
The Specific Aims of the Administrative Core are to:
Aim 1. Implement mechanisms and procedures that ensure ongoing interaction among the SAGE Steering Committee, the
Executive Committee members, postdoctoral fellows and junior investigators from underrepresented backgrounds (SAGE
Scientists) and the External Advisory Board.
Aim 2. Provide financial management, day-to-day administrative support, and metric-driven evaluation of progress to
ensure the efficiency and productivity of the SAGE Cores and the individual pilot projects.
Aim 3. Provide training opportunities, mentoring and support to enable the SAGE Scientists to successfully conduct trans-
disciplinary aging research integrating biological, social and behavioral sciences using emerging methodologies (precision
medicine, digital health, big data science and virtual reality & simulation based interventions).
Aim 4. Provide oversight for the pilot program implementation, ensure synergy across pilots and trace SAGE Scientists
on an ongoing basis through the period of the center award.
Aim 5. Provide oversight for human subjects, data safety and monitoring procedures for all the pilot projects and facilitate
timely communications with the institutional review board.
!